Diabetes, Macrophages and Bone Regeneration

Project Summary/Abstract
Both soft and hard tissue wound healing are impaired in type 2 diabetes (T2DM). Diabetes negatively impacts
fracture healing, bone regeneration and osseointegration of endosseous implants. The complex physiological
changes associated with diabetes are often manifest in immunological responses to wounding and repair where
macrophages play a prominent role in determining outcomes. Recent discoveries have demonstrated that the
immune system is tightly linked to bone physiology and immunomodulation of bone repair is affected by key
interaction involving macrophages and mesenchymal stem cells (MSCs). Yet, a fundamental knowledge gap
exists with respect to the nature of and the mechanisms that govern this interaction in the presence of T2DM.
My recent published study has revealed that the conditioned medium from diabetic mouse macrophages impairs
osteogenic differentiation of MSCs. My studies also show that macrophages secrete phenotype-dependent
extracellular vesicles (EVs) that affect the level of bone repair. Here, I hypothesize that diabetic macrophage
EVs mediate specific paracrine control of osteogenesis. To test this hypothesis, I propose two independent but
thematically related aims. In Aim 1, I will characterize and compare wild type mouse macrophage EVs
(wtEVs) and diabetic mouse macrophage EVs (dbEVs) at the structural and functional level and define the
effects of these EVs on MSC osteogenic differentiation quantitatively. I will demonstrate the role of macrophage
miRNAs cargo on osteoinduction by interfering miRNA function in Argonaute 2 (involved in RISC complex
formation and miRNA function) knockdown MSCs. In addition, I will validate that dbEVs contain miRNAs that
negatively influence the process of osteogenesis by generating EVs from DICER (required for mature miRNA
formation) knockout macrophages. In Aim 2, I will identify significantly distinct miRNAs in dbEVs, their target
genes and signaling pathways involved in osteogenesis by bioinformatic approach. I will evaluate the
functionality of these miRNAs on osteoinduction by utilizing mimics/antagomirs that increase or eliminate the
effects of identified miRNAs. I will study selected target genes at the level of miRNA interaction to affirm the
direct effects on gene regulation and downstream effects of these key miRNAs on osteoinductive pathways.
Translationally, I will generate functionally engineered EVs (FEEs) by engineer the candidate miRNAs (promote
osteogenesis) that rescue dbEV effects into MSC EVs. The FEEs will be characterized structurally and
functionally in vitro. Further I will utilize calvarial bone defect model to evaluate the function of selected miRNAs
within FEEs on bone healing in diabetic mice. Overall, these mechanistic studies will explore the significance of
the macrophage EV-mediated immunomodulation that occurs between macrophages and MSCs in the context
of bone healing in the presence of T2DM. These studies will refine knowledge of diabetic pathology and provide
potential targets for therapeutic intervention.

Public health relevance
Project Narrative Bone healing is impaired in type 2 diabetes (T2DM). This project will study the role of diabetic macrophage derived-extracellular vesicles and their unique/novel miRNA act in concert with mesenchymal stem cells to control bone repair and regeneration. Successful completion of this work will refine knowledge of diabetic pathology and provide potential targets for therapeutic intervention as well as further innovative ways to control inflammation and regeneration that influences bone repair in T2DM.